Gulf Coast Center for Precision Environmental Health

SUMMARY: OVERALL
The Texas Medical Center (TMC), encompassing the top research-intensive institutions in the Gulf Coast
Region, has emerged as an Environmental Health Sciences (EHS) research powerhouse, driven by the
establishment in 2019 of the Gulf Coast Center for Precision Environmental Health (GC-CPEH). The Strategic
Vision for the Center is to catalyze translational EHS research within research-intensive institutions of
the TMC to advance our understanding of individual- and place-based environmental determinants of
human health and disease. Home institutions for this multi-institutional Center are Baylor College of Medicine
(BCM), and the University of Texas (UT). As a new P30 EHS Core Center (EHS-CC), the GC-CPEH now ranks
#1 in Texas and #12 nationally in NIEHS grant support. Since its inception, Center members have worked
together to garner a new Training in Precision Environmental Health Sciences (TPEHS) T32, and successfully
competed for two large multi-institutional EHS programs: a P42 Superfund Center and a P50 Center for
Environmental Health Disparities Research. Coming into our fifth year and this competitive renewal, the GC-
CPEH has an outstanding cadre of 44 Full members, 320 publications citing the Center, and an NIEHS research
funding base of >$47 million. GC-CPEH member research coalesces into three Research Thematic Focus
Areas: Genome and Epigenome Environment Interactions (GE2), Mechanisms and Interventions in Human
Environmental Disease (MIHED), and new for this renewal, Current and Emergent Environmental Threats
(CEET) to human health. CEET retains Disaster Research Response (DR2) activities, and has been expanded
to include Veterans Environmental Health and Climate Change. The Goals for the GC-CPEH renewal are: 1)
Accelerate translational EHS research across disciplines and institutions of the TMC. This Goal advances
the Center's Translational Vision to drive precision environmental health research that will prevent
disease and improve human health; 2) Advance careers of the next generation of EHS researchers and
promote diverse perspectives to inform Center activities. This Goal is supported by an effective Career
Development Program and Plan to Enhance Diverse Perspectives (PEDP); 3) Build research capacity by
providing inter-institutional access to resources and technologies that accelerate research and translation via
the Pilot Project Program, seamless access to Next-gen technologies via the PIPELINE Facility Core and
enabling translational research through the Translational Research Support Core (TRSC). Utilization of these
Cores is facilitated by Navigators and the Matching Funds Core Utilization Program; 4) Support and
empower community engagement across the Gulf Coast region by linking community and investigators in
multi-directional communication activities that inform GC-CPEH research with an experienced and vibrant
Community Engagement Core (CEC) that fosters multi-directional communication with communities, and
informs environmental health policy for the greater Houston area and Gulf Coast Region.

Public health relevance
NARRATIVE The Gulf Coast Center for Precision Environmental Health serves as a focal point and catalyst for environmental health sciences research across the Texas Medical Center. Its members from Baylor College of Medicine and the University of Texas work together with an active Community Engagement Core to drive precision environmental health research to prevent disease and improve human health, and promote career development of junior faculty. Research in the Center is accelerated by services provided by the PIPELINE and Translational Research Support Cores, and a Pilot Project Program that together advance our understanding of individual- and place-based environmental determinants of human health and disease.